Coordination Center for Programs for Inclusion and Diversity Among Individuals Engaged in Health-Related Research (PRIDE)

PROJECT SUMMARY/ABSTRACT
Background: Some underrepresented groups are particularly susceptible to Heart, Lung, Blood, and Sleep
(HLBS) disorders. These disparities persist over time, even in the face of notable improvements in morbidity
and mortality rates overall. Since the diversity of the US population is increasing annually, there is a sense of
urgency to address these disparities now. The NIH is committed to recruiting and retaining a more diverse
workforce with the potential to contribute new ideas and innovative solutions to help reduce these disparities.
Objectives: In response to RFA-HL-24-003, this is a competing renewal to serve as the Coordination Center
(CC) for the Programs for Inclusion and Diversity Among Individuals Engaged in Health-Related Research
(PRIDE) (U24). The current PRIDE consists of 10 active Summer Institute (SI) research education training
programs with the general goal of providing research experiences, skills development and mentoring for early
career biomedical researchers from underrepresented groups. The CC will facilitate the coordination of
education and evaluation activities among the SI programs by facilitating: 1) the coordination of program-wide
activities (e.g., organization, outreach and recruitment, and candidate screening); 2) the education and support
through implementing the small research projects (SRP) and distributions of resources, tools and opportunities;
and 3) the development and implementation of an evaluation plan that integrates data from previous cohorts.
The evaluation protocol will assess key outcomes, collect and track outcomes across time, and benchmark
these outcomes against a comparison group of untrained faculty matched to the PRIDE participants.
Significance and Innovation: Since this is a competing renewal, the infrastructure and organization already is
operational, although we are prepared to make timely and efficient changes as needed. There is continuity,
with the contact PI having served in this capacity since the beginning of the project (over 17 years). Finally,
knowing whether the training has been successful depends on having relevant comparisons. Our application
specifically addresses this issue by adding an MPI who is trained in bioinformatics methods and has access to
unique electronic training education records for discovery and recruiting an appropriate comparison sample.
Methodology: This project is built around our web-based infrastructure that allows Public and Secure access
to program information, including our on-line data entry system, which will be upgraded and further automated
during the funding cycle. Summary: Our team has unique expertise and experience to continue as the CC for
the PRIDE and evaluate those indicators of success outlined in the RFA and this proposal. Further, we are
uniquely positioned to assess the impact of this program by benchmarking our results against a matched
comparison group, and look forward to tracking the career development of these bright and motivated
investigators as they lead us into the future.

Public health relevance
PROJECT NARRATIVE The PRIDE is a mentored summer training experience in developing research skills for early career-stage faculty who are underrepresented in the biomedical sciences. The Coordination Center tracks indices of career success (e.g., grant awards) over time to determine if these mentored training programs lead to increasing the diversity among individuals engaged in health related research.